Dopamine Dependence of Offset Analgesia

PROJECT SUMMARY
Chronic pain is ubiquitous, costly, and burdensome. Individuals with chronic pain suffer daily—the pain impairs
their ability to work, move, and live freely. On a societal level, chronic pain stresses both the healthcare system
and the economy. Despite its impact, there is no cure for chronic pain. The inability to properly treat chronic pain
has led to the current opioid epidemic. Although we are now beginning to understand the mechanisms underlying
chronic pain, we have few ways of assessing and probing these mechanisms. A chronic pain biomarker
mechanistically coupled to the circuitry responsible for inducing and maintaining chronic pain would help
researchers study and clinicians treat chronic pain.
Offset analgesia is a psychophysical phenomenon characterized by a transient, disproportionately large
decrease in pain following a slight reduction in noxious stimulus intensity. This phenomenon is both
mechanistically and clinically interesting. Mechanistically, it uncouples a noxious stimulus from pain qualia—two
often-conflated constructs. Clinically, it is blunted in patients with chronic pain, making it a biomarker for chronic
pain. Yet, we do not understand how offset analgesia occurs. By elucidating offset analgesia's mechanisms, we
will gain a greater understanding of the nociceptive-pain circuitry. Moreover, it would transmute offset analgesia
from a psychophysical correlate of chronic pain to a biomarker that provides neurophysiological insight.
This proposal aims to assess the dopamine dependence of offset analgesia. Although we do not know offset
analgesia's mechanisms, several lines of evidence suggest it may be dopaminergic. If the dopamine hypothesis
holds, then the core mechanisms responsible for chronic pain may also be responsible for mediating offset
analgesia. Aim 1 will attempt to generalize offset analgesia to other noxious stimuli since previous work has only
tested noxious heat stimuli. We will compare the offset analgesic response and dynamics between hot and cold
noxious stimuli. Establishing cold offset analgesia enables us to investigate its broader mechanisms by ensuring
our results are not specific to a single modality. Aim 2 will investigate the correlative role of nucleus accumbens
in offset analgesia. If the mesolimbic system is responsible for offset analgesia, its dynamics should capture the
temporal dissociation between the noxious stimulus (temperature) and pain ratings. Finally, in Aim 3, I will gain
experience in a clinical trial led by Dr. Apkarian that uses methylphenidate to perturb dopamine levels. An
increase in the offset analgesic response with methylphenidate relative to placebo would indicate dopamine
dependence. Understanding the dopamine dependence of offset analgesia is crucial to understanding its
underlying mechanisms and its use as a chronic pain biomarker.

Public health relevance
PROJECT NARRATIVE Dangerous stimuli are often coupled with pain; however, it is possible to uncouple a dangerous stimulus from the experience of pain by decreasing the dangerous stimulus's intensity to a less-but-still dangerous level. This uncoupling is called offset analgesia, and it is blunted in patients with chronic pain. This proposal aims to elucidate the core mechanism of offset analgesia, which may serve as both a clinical and mechanistic biomarker for chronic pain.